Endothelial Pannexin1 in Alzheimer’s Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease is the most prevalent form of dementia in the elderly and is associated with significantly
reduced cerebral blood flow resulting in a chronic state of cerebral hypoperfusion. Patients with Alzheimer’s
Disease have increased mortality from ischemic stroke possibly due to preexisting cerebral vascular dysfunction.
Thus, it is necessary to examine the mechanisms regulating vascular dysfunction in Alzheimer’s Disease to
identify potential therapeutic targets to mitigate cognitive decline and reduce ischemic injury in Alzheimer’s
Disease patients. Cerebral arteries become hyperconstrictive in Alzheimer’s Disease and have enhanced
responses to nucleotides, such as ATP. Pannexin1 channels in cerebral endothelial cells regulate the release
ATP, which subsequently activates downstream purinergic signaling cascades in the vasculature. Pannexin1
protein levels are significantly increased in cerebral tissue from mouse models of Alzheimer’s Disease. We
recently discovered that deletion or inhibition of endothelial Pannexin1 reduces cerebral artery myogenic tone to
improve cerebral blood flow. In addition to the role in the cerebral arterial vasculature, purinergic signaling is a
critical regulator of neuroinflammation in both Alzheimer’s Disease and ischemic stroke. We have also recently
demonstrated that deletion of endothelial Pannexin1 profoundly improves post-ischemic stroke infarct volume
through a reduction in leukocyte infiltration. Thus, endothelial Pannexin1 is a central regulator of both cerebral
arterial vascular tone and post-ischemic stroke inflammation. However, the role of endothelial Pannexin1 in
Alzheimer’s Disease and associated ischemic stroke during Alzheimer’s Disease is entirely unknown. We
hypothesize that cerebral endothelial Pannexin1 contributes to the development of vascular dysfunction and
ischemic stroke severity in Alzheimer’s Disease by increasing vascular tone and inflammation. We will use two
aims to test this novel concept. Aim 1 will define the role for endothelial Pannexin1 in regulating cerebral vascular
tone and cerebral blood flow during development of Alzheimer’s Disease. Using a mouse model of Alzheimer’s
Disease, the APP/PS1 transgenic mice, crossed with our novel transgenic mice conditionally lacking or
overexpressing endothelial Pannexin1, we will examine the development of cognitive and biochemical hallmarks
of Alzheimer’s Disease and evaluate cerebral arterial myogenic tone and cerebral blood flow. Aim 2 will examine
the role of endothelial Pannexin1 in ischemic stroke and neuroinflammation during Alzheimer’s Disease. We will
examine ischemic stroke outcome in our transgenic mice with Alzheimer’s Disease, evaluating pre- and post-
ischemic stroke neuroinflammation. Successful completion of our study identifying endothelial Panx1 as a novel
regulator of cerebral vascular function in Alzheimer’s Disease may provide a target for future therapeutic
intervention to improve cognitive function and reduce ischemic stroke injury in Alzheimer’s Disease.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease, the leading form of dementia in the elderly, is associated with reduced blood flow and increased inflammation in the brain. Alzheimer’s Disease patients have worse ischemic stroke injury, which may be due to preexisting vascular dysfunction, which can impair blood flow and increase inflammation. This proposal aims to evaluate the role of cerebral endothelial Pannexin1 in the development of vascular dysfunction in Alzheimer’s Disease and ischemic stroke outcome in Alzheimer’s Disease.